The molecular characterization of sex-specific piRNA transcription and snRNA transcription in C. elegans

Project Summary
The molecular characterization of sex-specific piRNA transcription and snRNA transcription in C. elegans.
PIWI-interacting RNAs (piRNAs) play key roles in repressing transposons in the germline. Loss of transposon-
targeting piRNAs can have sex-specific consequences leading to genomic instability and infertility. However, the
mechanisms of sex-specific piRNA expression remain largely unknown. Recent studies have revealed that
SNPC-4, a core factor required for snRNA transcription, is also essential for piRNA transcription in C. elegans
and suggests that the snRNA transcriptional machinery may have been co-opted to transcribe piRNAs.
Therefore, identifying the transcription factors and characterizing the specific protein domains that dictate sex-
specific piRNA and snRNA transcriptional specificity will address this critical knowledge gap. The small nuclear
RNA activating protein complex (SNAPc) is a conserved heterotrimeric complex consisting of SNAPC1,
SNAPC3, and SNAPC4 that facilitates snRNA transcription in mammals. Unlike mammals, C. elegans have
several orthologs of SNAPC1 that have sexually dimorphic roles in piRNA biogenesis. My preliminary data show
that SNPC-1.2 promotes female piRNA transcription while SNPC-1.3 is a known male piRNA transcription factor.
Furthermore, my initial data show the C. elegans SNAPC3 ortholog, SNPC-3.4, facilitates snRNA biogenesis,
while SNPC-3.1 and SNPC-3.2 act redundantly to drive both male and female piRNA expression. I will investigate
my hypothesis that SNPC-1.2 is a bona fide female piRNA transcription factor and harbors unique protein motifs
conferring female piRNA expression, while distinct domains in SNPC-1.3 specify male piRNA expression (Aim
1). Additionally, I predict SNPC-3.4 is a snRNA biogenesis factor, while SNPC-3.1 and SNPC-3.2 act redundantly
to drive piRNA transcription. Analogous to the SNPC1 family, I predict that distinct domains within SNPC-3.4
and SNPC-3.1/3.2 specify their recruitment and transcription at snRNA and piRNA genomic loci, respectively
(Aim 2). Collectively, these data will elucidate the snRNA and female and male piRNA transcriptional complexes
and identify the protein motifs that engender snRNA and sex-specific piRNA transcription. This work may have
implications in treating fertility defects that are due to abnormal piRNA expression as well as different neuronal
diseases associated with snRNA misregulation such as ALS.

Public health relevance
Project Narrative PIWI-interacting RNA (piRNA)-mediated silencing of transposable elements is critical in preserving the integrity of the genome in germ cells, with the loss of the piRNA pathway leading to sterility and potentially aging and cancer. Recent studies indicate that piRNAs are expressed in a sexually dimorphic manner and yet the mechanisms by which this occurs remains poorly understood. In this proposal, I aim to characterize the sex- specific transcription complexes that uniquely drive the expression of male and female piRNAs and explore the surprising molecular link to the transcription of snRNAs of the spliceosome.